Environmental Influences on Child Health Outcomes (ECHO) and Pregnancy in Ohio

The goal of the ECHO Ohio Cohort Site at Nationwide Children's Hospital and The Ohio State
University Wexner Medical Center (NCH-OSUWMC) is to contribute to the ECHO Cohort by
collecting and providing valuable data on a population of participating pregnant participants,
conceiving partners, and children who live in our region, so we can improve maternal and child
health everywhere by better understanding how exposures prior to and during pregnancy impact
childhood outcomes. The NCH-OSUWMC health system is highly experienced in contributing to
large multicenter NIH studies involving pregnant and child participants and well-poised to
contribute interdisciplinary leadership. We have maintained a large perinatal repository of clinical,
survey, and rich biospecimen data from pregnant participants, their partners, and their children for
over a decade. Our research coordinators and investigators are highly experienced in recruiting
both pregnant participants and children for research investigations and securely and efficiently
processing health data and biospecimens. Of note, our track record in retaining maternal/child
dyads, as well as conceiving partners, for follow-up is strong. We provide specific expertise in
evaluating lifestyle exposures in pregnancy, most prominently in maternal cardiovascular health,
and outcomes expertise in pre-, peri-, and postnatal health and childhood neurodevelopment. We
propose 1) evaluating the impact of maternal cardiovascular health during pregnancy using the
American Heart Association Life's Essential 8 framework on child development and behavior to
age 21, using existing ECHO Cohort Protocol core data elements and 2) investigating, using
innovative methods, the association between evolving maternal dysglycemia patterns across the
peripartum period and child socioemotional development and behavior while evaluating neonatal
anthropometrics as potential mediators. We propose to evaluate the interaction between genes
and lifestyle exposures on development via an association study complemented with imputed -
omics data. In a preconception-focused aim, we propose examining the impact of maternal and
paternal preconception cardiovascular health on development and behavior. Our contributions to
the ECHO cohort will enhance knowledge leading to improved child health.

Public health relevance
The ECHO Pregnancy Cohort will improve the health of children for generations to come by identifying how environmental exposures involving pregnant participants and their conceiving partners, before and during pregnancy, impact the health of their children from birth to the transition to adulthood. The ECHO Ohio Cohort Site will specialize in evaluating lifestyle exposures, in a group of pregnant participants and conceiving partners from preconception through the perinataI period, and their relationship to perinatal and chiId health outcomes. In addition to actively oontribut.ing to all area:s of ECHO data oolledlon and providing leadership for the program, we propose to focus on how cardiovascular health, including dysglycemia, during pregnancy are associated with an infant's health at birth and a child's neurodevelopment from birth to early adulthood.